Multimodal AI modeling of T cell therapies to predict patient response and nominate advanced cell design strategies

ABSTRACT
This project will develop novel multimodal artificial intelligence (AI) platforms to predict clinical
outcomes for patients treated with chimeric antigen receptor (CAR) T cell therapies and
nominate molecular engineering strategies to enhance therapeutic potency and safety. We will
build two complementary AI systems: (i) tcellGPT, which integrates single-cell multi-omic,
perturbation, and clinical datasets to predict patient response and toxicity based on the
molecular profile of infused CAR T cells, and (ii) tnicheAI, which maps the spatial organization
and functional state of the tumor microenvironment in multi-modal histopathology images and
integrates clinical data to identify suppressive niches that must be overcome by next-generation
CAR T cell designs. These models will be fused into tcellAI to holistically predict patient
outcomes by combining infusion product profiles, tumor characteristics, and clinical covariates.
Key outcomes will include predictive tools to personalize CAR T cell therapies, accelerate
preclinical development of novel cell engineering strategies, and elucidate biological
mechanisms underlying treatment efficacy and toxicity. Clinical team and bioethicists will be
engaged throughout to proactively address fairness, privacy, transparency, and accountability
considerations in the AI development lifecycle. The work will be conducted by a diverse team
spanning immuno-oncology, machine learning, clinical care, and bioethics to thoughtfully curate
datasets, tailor architectures, and validate predictive insights in alignment with stakeholder
needs. Ultimately, by enabling more effective, personalized, and equitable cell therapies, this
ethically-grounded multimodal AI approach will bring curative treatments to more patients.